Targeting M1/M3 Muscarinic Receptors to Treat Gestational Pesticide Poisoning

ABSTRACT
Poisoning with organophosphorus (OP) pesticides during gestation is a life-threatening condition for both
mothers and fetuses. Treatment relies heavily on the use of high doses of atropine to block muscarinic
receptor overactivation by acetylcholine (ACh) build up due to OP-induced block of acetylcholinesterase
(AChE). However, despite therapeutic intervention spontaneous miscarriages, infant and/or maternal deaths,
and postnatal neurological complications (including seizures and cognitive deficits) can ensue. Although rarely
taken into account, the non-selective inhibition of all muscarinic receptor (mAChR) subtypes by atropine may
be an important determinant of these poor outcomes. Specifically, inhibition of presynaptic mAChRs (mostly
M2), which are part of a negative feedback loop that limits ACh release from cholinergic neurons, can
exacerbate the OP-induced cholinergic crisis. The pharmacological profile of R,S-trihexyphenidyl (THP), a drug
that has been safely used during pregnancy and is approved for treatment dystonia and Parkinson’s disease,
makes it an attractive candidate to treat gestational OP poisoning. In contrast to atropine, THP more selectively
inhibits M1 and M3 than M2 mAChRs. In addition, THP inhibits as-of-yet unidentified subtypes of neuronal
nicotinic ACh receptors (nAChRs). Overactivation of M1/M3 mAChRs and neuronal nAChRs in the placenta
and myometrium, and in the cardiorespiratory and nervous systems can contribute to poor health outcomes
following acute OP intoxication during pregnancy. Thus, this project will test the hypothesis that, in part by
sparing M2 mAChRs and potentially by blocking nAChRs in addition to M1/M3 mAChRs, THP will be
more potent and efficacious than atropine to treat gestational OP poisoning. The focus will be on
chlorpyrifos (CPF), a widely used OP pesticide currently included in the U.S. Department of Homeland Security
Chemical Threat Risk Assessment list of chemicals that may be deployed to poison large numbers of people in
terrorist attacks. A multidisciplinary approach, a translationally relevant animal model (the guinea pig), and a
placebo-controlled, randomized, blind design that minimizes experimental bias and maximizes scientific rigor
will be used to address three aims. Aims 1 and 2 will establish the effectiveness of THP to save lives, reduce
signs of acute toxicity, and prevent the development of neurological complications in mothers and fetuses
gestationally exposed to a high dose of CPF. Aim 3 will shed light on the mechanisms that contribute to the
toxicity of CPF and the antidotal effectiveness of THP. Successful completion of this project will lay the
groundwork for the development of more effective antidotes to treat acute CPF intoxication during pregnancy.
Identification of therapeutic interventions that can have a positive impact on the health outcomes of populations
acutely intoxicated with OP pesticides lends support to the initiative of the World Health Organization to tackle
the issue of acute OP pesticide intoxication, particularly in the developing world. In addition, it fulfills an unmet
medical need for the effective treatment of victims of a deliberate attack with these pesticides.

Public health relevance
PROJECT NARRATIVE Each year, acute poisoning with organophosphorus (OP) pesticides takes the lives of hundreds of thousands of people worldwide. Short of actual prevention, the best hope to reduce the impact of acute OP intoxication rests on the development of more effective therapeutic approaches. Successful completion of this study will advance our understanding of pathophysiological mechanisms contributing to the poor health outcomes of OP poisoning during pregnancy. It will also establish the therapeutic potential of trihexyphenidyl (THP) to overcome lethality and neurological complications that result from gestational OP intoxication, a major public health issue especially in the developing world.